Development of monoclonal antibody-mediated interventions to combat malaria

This contract is to provide proof of concept studies for the development of a vector-based delivery of a potent P. falciparum-neutralizing monoclonal antibody.